Student Transformative Experiences to Progress Undergraduate/Graduate Professionals (STEP-UP) for cancer prevention

PROJECT SUMMARY / ABSTRACT
This application, entitled “Student Transformative Experiences to Progress Undergraduate and Graduate
Professionals” (STEP-UP) for cancer prevention, is a multidisciplinary research training initiative led by the
Health Promotion Sciences faculty and the University of Arizona (UA) Comprehensive Cancer Center, Cancer
Prevention and Control (CPC) Program. It is uniquely designed to provide 75 upper division undergraduate and
25 Masters' degree seeking students with an intensive, summer research experience in CPC over the grant
period. The research training includes immersion in mentor research laboratories and programs full-time for 10
weeks to experience CPC science across the entire continuum of basic to applied and even dissemination
research. Faculty mentor matching is carefully tailored to trainee interests, gaps in prior training, and career
goals, from 39 faculty members from diverse disciplines committed to this program who are funded in CPC
research. Trainees will also engage in weekly complimentary educational activities, including learning about
community engagement and career exploration and development. Educational pedagogy will inform on our
methodology in order to assure students receive a quality educational experience that not only will increase
understanding, but also will motivate students toward a continued educational commitment to advance in CPC
sciences. An embedded mentor development program will enhance faculty mentor training and engage
Masters' students and high-performing STEP-UP trainees, from past years, to serve as peer-to-peer mentors.
The STEP-UP program fills early gaps in our research training pathway programs, builds on purpose-driven
efforts at the UA Cancer Center to attract and retain a diverse student body in CPC research, leverages our
international reputation in CPC, supports continuous renewal of CPC mentors in academics and care through
the mentor training program, and has garnered significant institutional support. Our specific aims are: 1.
Recruit and retain undergraduate and Master's level graduate students into the STEP-UP research training
program; 2. Provide a multidisciplinary research training experience in CPC that strengthens self-efficacy and
intrinsic motivation to become a CPC scientist; 3. Support mentor training across academic stages, from
mentee to peer-to-peer up through senior faculty mentors, and cultivate professional relationships with
scientists, research programs, and community partners; 4. Conduct formative and summative evaluations to
improve the program over time. The training program is centralized in Southern Arizona and offers hands-on
research training within our unique catchment area which is rich in diversity relative to ethnicity (31.7%
Hispanic), race (5.3% Native Americans) and age (18.0% ≥65 years). This distinctive location, strong
community ties, university facilities and resources for research, as well as committed and experienced faculty
mentors and leaders, assures a quality program that will build and sustain the CPC workforce of the future.

Public health relevance
PROJECT NARRATIVE There continues to be a need to engage students in cancer prevention and control research early in their academic training to inspire cancer prevention and control careers and renew the pool of scientists and clinicians in the field. The overall goal of this program entitled, “Student Transformative Experiences to Progress Undergraduate and Graduate Professionals” (STEP-UP) for cancer prevention is to provide undergraduate and Masters' degree seeking students with an intensive, hands-on summer research experience in cancer prevention and control. This research training experience includes the conduct of a mentored research project, didactic instruction, and career development guided by highly experienced multidisciplinary leadership and mentoring teams with peer reviewed research funding, to assure a quality program that will build and sustain the cancer prevention and control workforce of the future.